Chronic Care Management of Geriatric Traumatic Brain Injury

ABSTRACT
Traumatic brain injury (TBI) is a leading cause of death and disability among older adults. Currently, there is a
lack of evidence to inform long-term care management of TBI in older adults. Once older adults return to their
community, it is unclear what type of rehabilitation services are received in the community setting. Significant
research has been conducted regarding the care received during inpatient rehabilitation and skilled nursing
facility care; however, it is unclear what type of home health and outpatient rehabilitation services are provided
to this growing population. Furthermore, social determinants of health (SDoH) are not well understood, as well
as their impact on utilization of rehabilitation services. Therefore, this Mentored Research Scientist
Development Award (K01) administrative supplement will extend the work done in the parent grant to
understand what rehabilitation services are provided to older adults once discharged to community and
whether differences in utilization are driven by SDoH. Dr. Pappadis is committed to conducting health
disparities research and is an advocate for diversity, equity, inclusion, and accessibility (DEIA). This
supplement will be used to address the following aims: (1) Characterize the utilization of rehabilitation services
during home health care or outpatient care in older adults with TBI following discharge to the community, and
(2) Examine the association between social determinants of health (SDoH) and utilization of rehabilitation
services during home health care or outpatient care in older adults with TBI following discharge to the
community. In addition, Dr. Pappadis will work with two student trainees who are interested in health disparities
and rehabilitation care delivery among older adults with TBI. During the supplement period, Dr. Pappadis, the
student trainees, and a network of rehabilitation professionals within a large rehabilitation medicine
organization will develop learning modules on inclusive mentoring for mentors and mentees. Dr. Pappadis will
also attend workshops and trainings to enhance her experiences in DEIA leadership and mentoring to improve
the mentor-mentee relationship and research environment for both. The findings from the work, as well as the
developed learning modules, will be disseminated within and outside of the institution in collaboration with the
student trainees.

Public health relevance
RELEVANCE TO PUBLIC HEALTH Older adults are at increased risk of sustaining a traumatic brain injury (TBI). Limited evidence exists on the patterns of care and services provided to older adults who transition home following acute or post-acute care hospitalization. Evaluating the provision of care and services following TBI is essential to identifying disparities in care and improving the quality of care for older adults with TBI.